SensiTrak: Automated Assessment of Forelimb Sensation

Project Abstract
Current common methods for measuring somatosensory function in preclinical rodent models
generally rely on withdrawal responses to uncomfortable or painful stimuli. These tests can be
stressful to the animal, while also yielding a high variability in measured responses, and
repetitive testing in longitudinal models may even result in chronic pain states. To better
understand the connection between physiology and perception of touch and proprioception,
researchers need a modern, off-the-shelf assessment system to administer and quantify trained,
volitional behaviors. Under this Phase II STTR project, Vulintus, Inc. will continue to develop and
validate ‘SensiTrak,’ an automated, high-throughput behavioral system designed to finely
measure somatosensory function in rodent models. SensiTrak meets the needs of
somatosensory-focused researchers by supporting complex, electromechanical feedback
interactions with animals, with interchangeable task modules, behavioral peripherals, and
open-source control software. Vulintus’ Phase II activities included finalization and certification
of a common controller and modules for assessing tactile, vibration, and proprioception
discrimination thresholds. Concurrently, SensiTrak systems will undergo beta testing at two
different laboratories at Columbia University and the Winifred Masterson Burke Medical
Research Institute. Beta testing will help establish the reliability and utility of SensiTrak
assessments and will guide the development of protocols for other laboratories to follow when
adopting SensiTrak in their research. At the conclusion of this Phase II, a fully developed
SensiTrak product line will provide researchers with unprecedented capabilities to reliably
measure tactile and proprioceptive function in early preclinical animal models, and will help to
improve the rate of successful translation of promising therapies from preclinical investigations
to clinical practice.

Public health relevance
Project Narrative Current methods of assessing somatosensory function in preclinical animal models largely depend on withdrawal responses to uncomfortable or painful stimuli, which do not correspond well to clinical tests of touch and proprioception. In this Phase II STTR project, Vulintus, Inc., continues development of ‘SensiTrak,’ an automated, high-throughput operant behavioral system designed to finely measure somatosensory function in rodent models. SensiTrak systems will provide researchers with unprecedented capabilities to reliably measure tactile and proprioceptive function in early preclinical animal models, and will help to improve the rate of successful translation of promising therapies from preclinical investigations to clinical practice.